Deciphering interactions between human T cells and cardiomyocytes in immune checkpoint inhibitor-related myocarditis

PROJECT SUMMARY
Severe immune-related adverse events (irAEs) such as immune checkpoint inhibitor-related myocarditis
(irMyocarditis) are poorly understood and potentially life-threatening side effects caused by immune checkpoint
inhibitors (ICIs). Steven Blum, MD is an Instructor of Medicine at Harvard Medical School and an Assistant in
Medicine at the Massachusetts General Hospital (MGH) in the Division of Hematology/Oncology. His long-term
goal as a physician scientist is to utilize patient samples and human models to design therapeutic strategies
that reduce the impact of irAEs – starting with irMyocarditis – without blunting ICI efficacy. The overall objective
for this application is to determine the drivers of irMyocarditis and therapeutically modulate interactions
between T cells and cardiomyocytes using patient samples and model systems. The central hypothesis is that
autoreactive T-cell clones expanded in irMyocarditis tissue recognize novel autoantigens and utilize targetable
programs to drive irMyocarditis pathogenesis that are distinct from programs driving anti-tumor immunity. The
rationale for this project is that the T cell-mediated killing of cardiomyocytes defines the pathology of
irMyocarditis, but the interactions between these cell types remain poorly defined. Dr. Blum will test this
hypothesis through three specific aims: (1) define cardiomyocyte-reactive T-cell clones; (2) identify pathogenic
interactions between T cells and non-immune cells; and (3) modulate T cells therapeutically to prevent
cardiomyocyte death while allowing tumor cell killing in vitro. In Aim 1, he will determine which T-cell receptors
(TCRs) isolated from the hearts of irMyocarditis patients recognize cardiomyocytes and identify antigens
recognized by these TCRs. In Aim 2, he will use spatial profiling approaches to identify targetable interactions
between T cells and non-immune cells. In Aim 3, he will test potential therapies in parallel co-culture models of
(i) T cells with cardiomyocytes and (ii) T cells with tumor cells. He will then develop a clinical trial protocol to
test the efficacy of a candidate treatment to mitigate irMyocarditis in patients. This research can offer significant
contributions to the understanding and management of irMyocarditis and irAEs more broadly. Dr. Blum has
outlined a five-year career development plan consisting of coursework, conferences, seminars, and structured
mentoring in T-cell manipulation, antigen recognition techniques, spatial transcriptional profiling, and in vitro co-
culture modeling to perform his research and reach his goal of becoming an independent investigator. Dr. Blum
will pursue the training outlined in this K08 Award proposal under the guidance of an experienced,
interdisciplinary mentoring and advisory team from MGH, the Dana-Farber Cancer Institute (DFCI), and the
Broad Institute. His team is led by his primary mentor, Dr. Alexandra-Chloé Villani (MGH), and includes his co-
mentors, Drs. Ryan Sullivan (MGH) and Catherine Wu (DFCI). He will maintain ≥80% of his time for research.
Training in this exceptional environment will help Dr. Blum obtain the necessary experience and skills to
become an R01-funded independent investigator in the field of immuno-oncology.

Public health relevance
The proposed research is relevant to public health because it aims to mitigate severe immune-related adverse events (irAEs) – the dangerous, morbid, and increasingly common side effects of immune checkpoint inhibitors (ICIs). This project focuses on a particularly lethal irAE known as ICI-related myocarditis (irMyocarditis) and uses patient samples and human models to develop a deeper mechanistic understanding and targeted therapies to treat irMyocarditis while preserving anti-tumor immune responses. The proposed research is directly relevant to the NCI’s mission to help cancer patients live longer, healthier lives.